Cell Surface Marker Combinations to Identify Latently Infected CD4+ Cells In Vivo

DESCRIPTION (provided by applicant): A major hurdle in achieving a cure for HIV-1 is the existence of reservoirs of persistent viral infection, with resting memory CD4+ T cells being the largest and best studied. In these cells, HIV-1 rests as a latent provirus refractory to antiretroviral therapy (ART) and invisible to immune surveillance, which can be reawakened and spread the infection. In recent years there has been a push to develop therapies targeting latently infected CD4+ T cells. The shock and kill approach seeks to flush latent provirus with anti-latency drugs that do not cause global T cell activation, and in the presence of ART to prevent the flushed virus from spreading the infection. However, recent evidence suggests that this approach may be inadequate. Our long-term goal is to develop strategies to directly target and deplete latently infected CD4+ T cells without reactivating the provirus. Our central hypothesis is that surface markers differentially expressed on latently infected CD4+ T cells may be used to achieve that goal. With the support of an NIH-funded grant, we profiled the transcriptome of latently infected and uninfected CD4+ T cells generated with our in vitro latency model, and we identified 33 differentially expressed surface markers. We also found that one of the receptors identified in the microarray screen - CD2 - is expressed at higher levels on latently infected resting memory CD4+ T cells of HIV-1 subjects under suppressive ART. The present application proposes to further pursue these studies with the aim of establishing a panel of cell surface markers that when used in combination will allow to identify with high specificity latently infected resting memory CD4+ T cells in vivo. Thus, in Specific Aim 1 we propose to use our in vitro latency model to validate all the surface markers differentially expressed in the microarray study, and to understand why latently infected cells present that specific expression profile. Specific Aim 2 proposes to validate the markers identified in the previous specific aim, and to generate a panel of surface receptors to define with high specificity latently infected CD4+ T cells in peripheral blood and lymph nodes of HIV-1 patients. The expected outcome of these studies is the establishment of a panel of cell surface markers that in combination will define with high specificity latently infected resting memory CD4+ T cells in vivo. These markers can be used to monitor the size of the latent reservoir in the clinical setting, to enrich latently infcted CD4+ T cells in the laboratory setting, and possibly as a therapeutic target to deplete the latent reservoir without reactivating the provirus. This work is a partnership with Nicolas Chomont at VGTI-Florida, who developed ultra-sensitive techniques to measure integrated HIV-1 provirus in clinical samples, and viral RNA after ex vivo reactivation.

Public health relevance
PUBLIC HEALTH RELEVANCE: Resting memory CD4+ T cells harboring HIV-1 provirus in a dormant state are virtually indistinguishable from uninfected cells and represent the major obstacle to viral eradication and to achieving a cure. Recent evidence suggests that current strategies aimed at the elimination of these cells with drugs that reactivate the dormant virus may be ineffective. This project seeks to uncover surface markers that when used in combination would identify latently infected cells with high specificity, and possibly open the way to new therapeutic strategies for their elimination. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS HIV-1 establishes persistent infection in many cell types even in patients effectively treated with highly active antiretroviral therapy (HAART) for many years. The largest reservoir of persistent HIV-1 infection consists of latently infected CD4+ T cells, which harbor stably integrated HIV-1 in a dormant state for years until they become activated and once again begin releasing infectious virions. Therefore, latency allows HIV-1 to evade immune responses and to persist during HAART, and represents the major obstacle to achieving a cure. Current strategies to eradicate or reduce the latent reservoir are predicated on the notion that reactivation of the latent provirus would lead to the demise of the infected cell. Recent studies have put this concept into question, underscoring the need for additional approaches to target latently infected cells. The identification of surface markers on latently infected CD4+ T cells might allow new therapeutic avenues. As part of a previously NIH-funded study, we established an in vitro model of HIV-1 latency in CD4+ T cells that we used to profile the entire transcriptome of quiescent latently infected and uninfected cells purified to near homogeneity from the same culture. This analysis revealed differential expression of messenger RNA for 33 cell surface markers in latently infected vs. uninfected cells. In the preliminary studies for this application i) we have confirmed differential expression by quantitative RT-PCR; ii) we verified differential expression of three receptors (CD2, CD6, and ILRB) by flow cytometry using cells generated with our in vitro model; and iii) we validated differential expression of one receptor (CD2) on latently infected resting memory CD4+ T cells isolated from peripheral blood of five HIV-1 patients under suppressive antiretroviral therapy. Our preliminary work warrants further investigation of all other receptors identified in the microarray study with the overall aim of developing a panel of surface markers that when used in combination will allow to identify latently infected CD4+ T cells in vivo with high specificity. These studies will be conducted in two Specific Aims: 1. Identify cell surface markers differentially expressed on latently infected CD4+ T cells generated with an in vitro culture system. We will use our in vitro latency model to identify surface markers on latently infected CD4+ T cells by validation of microarray results (Study #1), and to understand why latently infected cells present that particular surface expression profile (Study #2). 2. Define a panel of cell surface markers to identify latently infected CD4+ T cells in peripheral blood and lymph nodes of HIV-1 infected subjects under suppressive ART. We will use clinical samples to validate all differentially expressed markers identified in Specific Aim 1 (Study #1), and to define a panel of surface markers that define latently infected CD4+ T cells present in peripheral blood (Study #2) and in lymph nodes of HIV-1 patients under suppressive ART (Study #3). The expected outcome of these studies is the establishment of a panel of surface markers that in combination will identify with high specificity latently infected resting memory CD4+ T cells in vivo. These results are expected to have a positive impact because they would allow the enrichment of latently infected CD4+ T cells from clinical samples, opening the way to more detailed studies. In addition, these results would allow testing new therapeutic strategies aimed at eliminating or decreasing the size of the latent HIV-1 reservoir.